Cancer Prevention and Control

UWCCC Cancer Prevention and Control (CPC) Program Summary
Co-Leaders: Lisa Cadmus-Bertram and Nihal Ahmad
PROJECT SUMMARY/ABSTRACT
The Cancer Prevention & Control (CPC) Program spans basic, clinical, and population science to identify
effective approaches to reduce the burden of cancer for patients, their families, and communities through
improved prevention, early detection, and survival. In support of this overarching goal, the CPC program has
defined three thematic aims. Aim 1: Identify novel targets, biomarkers, agents, and strategies for cancer
prevention and risk reduction. Members continue to have national impact through tobacco cessation,
chemoprevention, and vaccine intervention science including drug development, clinical trial conduct, and
generating evidence to guide health policies. The UWCCC impacts national strategies for implementing
prevention research by directing the coordinating centers for the NCI-supported Cancer Center Cessation
Initiative and the Chemoprevention Consortium. Aim 2: Evaluate biopsychosocial factors and interventions
that influence the patient and family experience of cancer and supportive and palliative care needs.
Members conduct observational and interventional studies to characterize symptom experiences. Members also
develop and test pharmacologic, cognitive, and behavioral lifestyle intervention strategies to improve patient-
and family-centered outcomes across the survivorship continuum, from diagnosis through end of life. Aim 3:
Conduct health services research, emphasizing provider and system factors, with the goal of enhancing
the quality of cancer care. Members identify effective approaches for improving delivery of cancer screening
tests, diagnostic examinations, and cancer therapies. CPC members are using innovative simulation modeling,
bioinformatics, and multidisciplinary teams to improve the early detection and treatment of cancer, and to
leverage insights obtained through analysis of large databases to test approaches for improving access to
guideline-concordant clinical care. Across these three aims, CPC projects directly address the priorities of the
UWCCC catchment area including the elimination of cancer health disparities. The CPC Program has 40 CCSG
members in 17 departments and 6 schools/colleges. Since 2017, CPC members published 791 peer-reviewed
manuscripts (22% intra-programmatic, 22% inter-programmatic, 56% inter-institutional). PIs hold $14.2 million
(direct costs) in cancer-related grant funding with $6.5 million (direct costs) from NCI. The CPC Program supports
inter- and intra-programmatic interaction through pilot grants, seminars and retreats, experienced mentoring,
and collaborative working groups informed by evidence-based approaches from team science scholarship.
Guided by programmatic and center-wide strategic planning, priorities for the CPC program over the next 5 years
include addressing the challenges related to expanding survivorship studies, reducing cancer health disparities,
expanding precision prevention research, and expanding studies of colorectal and lung cancer early detection.
Thus, the overall objective of CPC is to reduce the burden of cancer for patients, their families, and communities
via improved prevention, early detection, treatment delivery, and survivorship support.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.